Migration and resolution, lung microenvironment and mechanisms: examining the diverse responses of neutrophils during S. pneumoniae pneumonia and acute lung injury

Bacterial pneumonias remain important clinical problems with major morbidity and mortality. S. pneumoniae is
the leading cause of community-acquired pneumonias and an important cause of ARDS and post-viral bacterial
pneumonias. The lung's immune response is critical to clearance of S. pneumoniae, repair of the lung tissue,
and return to homeostasis. Our studies have addressed many aspects of neutrophil kinetics and function and
document the numerous ways in which neutrophils vary and can be categorized, based on cytokine production,
surface markers, transcriptomes, age, or many other criteria, each of which describes the range of functions that
neutrophils can perform. This proposal focuses on the mechanisms underlying the process through which
neutrophils function to identify and repair the infection and injury and/or to further injure the lungs. Our overall
working hypothesis is that during the immune response, neutrophils undergo changes in their transcriptomes
that regulate their function and that the unique structure of the lungs creates microenvironments within the
parenchyma and the alveoli/small airways that regulate the phenotype of neutrophils. We further postulate that
spatial and temporal features of the innate immune response contribute to this phenotype. Aim 1 will determine
the changes that neutrophils undergo as they are recruited and carry out their functions during S. pneumoniae
pneumonia and the biological importance of these changes. We will determine the changes in the transcriptome
of neutrophils in the systemic blood, pulmonary capillary blood, lung parenchyma and alveoli/airways at 6h, 18h,
2d and 4d after inoculation, identifying both spatial and temporal changes in neutrophil transcriptomes using
scRNAseq/CITE-seq. We postulate that heterogeneity in endothelial and alveolar Type 1 and 2 cell
transcriptomes will describe niches of migration. Protein expression of identified neutrophil proteins will be
assessed using mass cytometry. The mechanisms underlying the phenotypes of neutrophils expressing IFNγ,
IL-1α and/or TNF and of SiglecF+ neutrophils will be studied. Aim 2 will determine the changes in the lung
microenvironment during the development and resolution of S. pneumoniae-induced inflammation and injury.
The spatial transcriptome of alveoli and bronchioles/bronchi will be determined 6h, 18h, 2d and 4d after
inoculation of S. pneumoniae. The effect of signaling induced by Type I and II IFNs, IL-1α/β and TNF on
neutrophil transcriptomes and function will be identified. The hypothesis that the oxidative microenvironment
experienced by myeloid cells contributes to transcriptomic heterogeneity and function will be tested. These
studies will determine the changes in neutrophils as they function during pneumonia, will compare neutrophils
defined by particular criteria, and will shed light on the changes and contributions of the lung microenvironment
as inflammation develops and resolves. They will reveal novel context-dependent relationships and
interactomes, providing insight into neutrophil function in the innate immune response and potential therapeutic
opportunities for bacterial pneumonia.

Public health relevance
Bacterial pathogens cause pneumonia and lung injury, and S. pneumoniae is an important and common cause, particularly of community-acquired pneumonia as well as nosocomial pneumonia and bacterial pneumonia secondary to viral infections. The immune response of the lungs and the functions of neutrophils in the lungs are critical to clearing the bacterial infection and resolving the infection without inducing excessive injury. Using forefront technologies, our studies investigate the mechanisms of the immune response in the lungs in response to S. pneumoniae, including the heterogeneity in gene expression over time in neutrophils, the biological importance of this heterogeneity, and how the heterogeneous response is generated, offering insight into therapeutic opportunities targeting neutrophils that are not yet appreciated.